28th International Workshop on Retroviral Pathogenesis

Project Summary/Abstract The International Workshop on Retroviral Pathogenesis, now in its 28th year, has long served as a forum for the exchange of new research findings and concepts on all aspects of retroviral pathogenesis from molecular mechanisms to the immunological parameters of host-virus interaction. The conference will continue a tradition of intimate, engaged scientific interaction on all aspects of retroviral pathogenesis with strong emphasis on animal retroviruses as models for human disease. Retroviral pathogens of humans and animals in all retroviral genera are the subject of scientific presentation and vibrant discussion. Topics at the workshop will include retrovirus entry and integration, replication and restriction, assembly, immune responses, oncogenesis, pathogenesis, new and emerging pathogens, endogenous retroviruses, and animal models of disease. Approximately 75 participants are anticipated, including principal investigators, postdoctoral trainees and graduate students. Planned for December 5 – 9, 2016 in New Orleans, Louisiana, the small size and format of the conference supports concentrated interaction and deep scientific engagement. The conference fosters the professional development of junior investigators by affording them the opportunity to present their current work to a panel of engaged colleagues and to serve as session moderators. The overarching goal of the conference is to provide a forum that fosters continued scientific engagement leading to innovative conceptual advances and research in the area of retroviral pathogenesis, broadly defined. The conference will address this goal through four specific aims: (1) Bring together national and international scientific leaders in the field, together with junior investigators, postdoctoral and student trainees; (2) Provide opportunities for scientific presentations and discussions as a group, interspersed with more intimate opportunity for discussion and interaction; (3) Provide platform opportunities for junior investigators, women and underrepresented minority scholars through scientific presentation and/or designation as session moderators; and (4) Provide registration scholarships to outstanding undergraduate students and a faculty advisor selected among participants in the NIH-funded “Building Integrated Pathways to Independence for Diverse Biomedical Researchers (BUILD)” Program at Xavier University, a leading HBCU located in the conference city.

Public health relevance
Project Narrative Retroviruses have long been recognized as important pathogens of humans and animals, and research on these agents has uncovered important mechanisms in human disease. The 28th International Workshop on Retroviral Pathogenesis will continue a long tradition of intimate, engaged scientific interaction on all aspects of retroviral pathogenesis with strong emphasis on animal retroviruses as models of human disease. The conference will convene national and international scientific leaders in the field, together with junior investigators, postdoctoral and student trainees, for scientific presentation and engaged discussion.